NATURAL HISTORY STUDIES IN NEUROMUSCULAR JUNCTION (NMJ) DISEASE MOUSE MODELS

Establish the ColQ -/- mouse colony including breeding, genotyping and natural history characterization. The primary objective of this task is to establish the colony of the CMS mouse model and obtain a natural history characterizing aspects related to growth and muscle strength.